Differentiation in Yeast: Mechanisms of Mating and Meiosis

Eukaryotic cells fuse during fertilization to produce diploid zygotes that go on to differentiate into specialized
cells during development. Somatic cell fusion also occurs during development to produce multinucleate
tissues, such as myoblast fusion to form muscle. Diploid organisms may then undergo meiosis to produce
haploid gametes for subsequent fertilization, completing the cycle of sexual reproduction. Cell fusion and
meiosis must be tightly regulated. Inappropriate cell fusion, as occurs in some virally-infected cells and
metastatic cancers, results in pathological syncytia. Despite advances in elucidating the process of cell fusion,
much remains unknown. Meiotic defects may cause aneuploidy, or even sterility. Recent research revealed
that meiotic regulation is surprisingly complex. Overlaid on waves of transcriptional regulation are complex
layers of mRNA modification and translational regulation which are thought to provide exquisite temporal
control. However, much remains to be learned about how meiosis is regulated. The long-term goals of the
research in my lab are to understand the fundamental, conserved molecular mechanisms of cell fusion, nuclear
fusion, and meiotic regulation using one of the most powerful model organisms, the budding yeast
Saccharomyces cerevisiae. During yeast mating and somatic cell fusion, cells must signal that they are in
contact and competent to fuse, remove the extracellular matrix separating them, and fuse the plasma
membranes. Each step is only poorly understood. We have shown that in yeast, as in mouse myoblasts,
Cdc42p is a key regulator of cell fusion. We will address how cell contact regulates Cdc42p and how Cdc42p in
turn mediates cell fusion, focusing on membrane curvature and the cell wall integrity pathway. Using a novel
genetic screen, we will pursue identification of the yeast membrane fusogen. After mating and cell fusion,
many induced proteins may be hazardous and must be rapidly degraded. We discovered that Srl4p stabilizes
mating-induced proteins by inhibiting a branch of the proteasomal degradation pathway. We will examine how
Srl4p differentially regulates the turnover of proteins in mating and mitosis. After fertilization in many
organisms, the pronuclei fuse. Nuclear fusion is a challenging biological problem – how do the two membranes
fuse sequentially and in register? We identified Kar5p, a protein conserved in plants, animals, and fungi, as
mediating nuclear envelope fusion; however, its precise role is unknown. We will test our hypothesis that Kar5p
acts as a novel inner nuclear envelope fusogen. In meiosis, mRNA N6-adenine methylation has been revealed
to be a critical regulator, although its functions are not yet understood. Kar4p is the yeast homologue of human
METTL14, a core component of the methyl-transferase. Surprisingly, we found that Kar4p regulates both
meiotic transcription and meiotic protein levels. We will examine how Kar4p regulates meiosis at multiple
levels, testing potential roles in transcription, translational regulation, and mRNA modification. Our studies will
aid the understanding of basic conserved mechanisms of cell fusion, nuclear membrane fusion, and meiosis.

Public health relevance
Cells fuse during fertilization and development, creating diploid organisms, and then undergo meiosis to produce haploid gametes for fertilization. Problems any of these processes can lead to significant health effects. This project studies these processes in a model organism, baker's yeast, which uses genes similar to the human genes, to provide understanding of their roles in human cell biology and disease.